Novel rhoptry protein function in chronic toxoplasma infection

Reactivation of dormant Toxoplasma gondii bradyzoite cysts in the central nervous system in AIDS patients causes Toxoplasmosis, a dangerous and difficult to treat recurrent encephalitis. No treatments are currently available for AIDS patients to eliminate the dormant Toxoplasma bradyzoite cysts, to prevent their reactivation, or to prevent the development of new cysts after reactivated disease occurs. The absence of any current curative or preventative treatment for AIDS patients to reduce the risk of disease associated with Toxoplasma infection is due primarily to a major gap in basic knowledge regarding the fundamental parasite biology of chronic infection. Several Toxoplasma rhoptry secreted (ROP) protein virulence factors are crucial for parasite survival during acute infection and enable parasite survival necessary to establish the chronic stages of infection defined by bradyzoite cysts. Our recent findings identified novel rhoptry proteins encoded by the ROP38 locus that while essential for the chronic bradyzoite cyst stages are not necessary for the acute stages of infection or parasite virulence. Consequently, investigation of the ROP38 locus enables a specific analysis of mechanisms that influence cyst burdens in chronic infection. The ROP38 locus contains 6 genes that encode ROP proteins with signatures of active kinases (ROPKs). In this exploratory R21 project we will examine aspects of host - parasite interaction and mechanisms associated with the ROP38 locus that are crucial for chronic stages of infection. This is a novel area of biological investigation because the existence of ROPKs that control chronic infection but not acute infection were previously unknown. Through the investigation of the biological functions of the ROP38 locus, this high risk - high impact exploratory R21 study has the potential to reveal new aspects of parasite biology.

Public health relevance
Reactivation of dormant Toxoplasma gondii bradyzoite cysts in the central nervous system in AIDS patients causes Toxoplasmosis, a dangerous and difficult to treat recurrent encephalitis. The absence of any current curative or preventative treatment for AIDS patients to reduce the risk of disease associated with Toxoplasma infection is due primarily to a major gap in basic knowledge regarding fundamental parasite biology of chronic infection. By examining fundamental parasite mechanisms associated with the ROP38 locus that are crucial for chronic stages of infection, we expect to identify biology that can inform new strategies to target the chronic stages of this parasite.